Population Science Data Commons

• The vision for a Cancer Research Data Commons is a virtual, expandable infrastructure that will eventually support collaboration among researchers, computational scientists, and tool developers. It will house multiple cloud-based Commons Nodes for multiple data types, initially including genomic, imaging, proteomics and population sciences data. In the future, additional nodes will support other data types. Genomics data in the CRDC is supported by the Genomic Data Commons (GDC), which provides a means of data submission, user interfaces, and search & visualization tools. The overarching vision for this task order is to develop the Population Sciences Data Commons (PSDC) to make population sciences data more broadly accessible to the cancer research community and to connect investigators with diverse subject matter expertise with cancer research data The PSDC should incorporate data from various NCI population-based sciences programs and awards including the Cancer Epidemiology Cohorts.